Administrative Core-CAMIPM

CAMIPM ADMINISTRATION
ABSTRACT
The proposed NCBIB “Center for Metabolic Imaging in Precision Medicine (CAMIPM)” has an administrative
Core that coordinates all activities in the Center. Prof. Ravinder Reddy, P.I. and Director, an accomplished leader
in the field of magnetic resonance, will have the overall responsibility of all Center activities and operations.
The Director will be assisted by an internal Executive Committee comprised of four Associate Directors (Ari
Borthakur PhD, Mark Elliott PhD, Dushyant Kumar PhD, Susan Colleluori, BS) and Clinical Directors (Dr. Mitch
Schnall, MD/PhD, and John Detre, MD). The committee will meet every month to oversee progress in each
components of the Center i.e. collaboration, service, training and dissemination. Ms. Colleluori serves as the
Associate Director for Administration and has more than 25 years-experience in supporting fiscal operation at
the Center. In her capacity, she works closely with the business office of Department of Radiology of the
Perelman School of Medicine at the University of Pennsylvania (UPenn) in managing day-to-day operations of
the CAMIPM.
In addition, there will be a monthly TR&D leader meeting that will also include the Executive Committee.
During this meeting, one of the TR&D leaders will present their Core’s progress, following which the other TR&D
leaders and members of the Executive Committee will discuss the quality and quantity of progress in each
component of the Center.
The Center will have a Clinical Advisory Board comprising of expert clinician scientists from UPenn who will
advise the Center on issues regarding human studies, safety, and associated regulatory issues. In addition, the
Radiology department’s Center for Advanced Magnetic Resonance Imaging and Spectroscopy (CAMRIS) and
Small Animal Imaging Facility (SAIF) committees provide support for human, and animal experiments,
respectively.
Finally, the Center also will have an External Advisory Committee, comprising of leaders from the field, who
meet yearly to review the progress of the Center and generate a report for submission to the NCBIB coordinating
program at the NIBIB. This committee will also advise the PI on the overall programmatic vision of the Center.